Research Ethics and Dissemination (READ) Core

PROJECT SUMMARY
The mission of the Research Ethics And Dissemination core is to provide investigator centered
services to support high quality research and ensure compliance with federal, institutional and American Indian
tribal regulatory requirements for community-linked, transdisciplinary human subjects' research. This core
builds upon the existing Regulatory Knowledge Core of the Collaborative Research Center for
American Indian Health (CRCAIH), funded by the National Institute of Minority Health and Health
Disparities (NIMHD U54MD008164). In the proposed application, we will expand the services of the
Regulatory Knowledge Core to focus on precise needs of COBRE Project Leaders, with the ultimate goal to
help create a pathway towards an independent research program.
The READ core will reduce the regulatory burden for investigators and optimize the use of resources by
providing investigator support and guidance with Institutional Review Board (IRB) applications, including
protocol and consent development, for research projects involving multiple sites and partners. As applicable,
the core will lead the efforts for navigating the complex regulatory environment of multi-site research including
research with American Indian tribal communities, to allow for timely initiation of the research projects. The
READ core will also serve as a central repository of regulatory documentation, monitor timelines for IRB
approvals and help minimize any issues related to investigator non-compliance, by providing guidance with
study records management and periodic monitoring of research protocols. The READ core will identify gaps in
training and provide tools and resources to increase investigator and IRB member knowledge of community
based research to promote consistency in IRB review and build institutional capacity in this area. A special
emphasis will be placed on the unique operational challenges involved in review of community based research
that may lead to unnecessary delays in the review process. The READ core will also help the COBRE Project
Leaders disseminate research progress and findings back to communities. This communication and
engagement throughout the research process is vital to enhancing stakeholder engagement, building trust and
maximizing community/tribal benefit from involvement in research.

Public health relevance
PROJECT NARRATIVE The potential impact of Research Ethics and Dissemination Core is to increase investigator knowledge and capacity to successfully execute high quality research in our region. Armed with the right knowledge and tools, the COBRE investigators will be able to develop and sustain their research programs in a systematic manner. By synergizing and expanding with other existing core resources, the Research Ethics and Dissemination core will increase institutional capacity to seamlessly navigate all regulatory and compliance issues and minimize the burden associated with less than optimal research review and approval processes.